EFFECT OF SHORT TERM WEIGHT LOSS ON INSULIN SENSITIVITY IN CHILDHOOD OBESITY

The relationship between insulin sensitivity, hypertension, physical fitness, body composition and weight reduction in childhood obesity.